Deciphering mechanisms that drive collective cell migration

PROJECT SUMMARY
Collective cell migration is the most prevalent form of cell migration in the body; it is involved in the construction
and repair of almost all human tissues. Previous work by the PIs has provided novel insight on the hierarchy of
individual cell behaviors and intracellular signals that drive collective migration. This work identified activation of
the intracellular signal PLCg1 as strongly correlated with increased collective migration and cell migration
persistence. The proposed study aims to elucidate the mechanisms by which PLCg1 drives collective migration
and will yield both novel tools and knowledge that may be applied to control this process. We will achieve this
goal by:
1) Determining the mechanism(s) by which PLCg1 activation yields cytoskeletal remodeling. We will develop
a FRET-based PLCg1 reporter and identify the downstream effectors of PLCg1 that drive cytoskeletal
rearrangement, a critical component of cell movement.
2) Elucidating the biophysical mechanisms by which PLCg1 activation translates into directed collective
migration. We will develop cellular models with varying levels of constitutively active PLCg1 and apply
traction force microscopy to analyze how cytoskeletal forces are transmitted to yield collective cell
movement.
3) Determining optimal patterns and extent of PLCg1 activation needed for robust collective migration. We
will develop an optogenetic approach to stimulate different spatio-temporal dynamics of PLCg1 activation
during directed keratinocyte migration.
By employing a combination of innovative molecular and biophysical tools, we aim to uncover mechanistic
knowledge that allows us to gain control over collective epithelial migration. Identifying the pathway(s) by which
PLCg1 activation connects to downstream signals, as well as its spatial and temporal dynamics within the
collective sheet, provides opportunities to regulate both healthy and pathological collective migration across a
range of tissues and pathologies. Elucidation of these pathways and cues provides an important foundation for
targeting specific elements to induce collective movement in conditions where it is impaired (e.g., chronic would
healing) or to halt collective movement in conditions where it is pathological (e.g., cancer).

Public health relevance
PROJECT NARRATIVE Collective cell migration is a process by which cells move in concert with each other that occurs across all stages of human development, as well as in tissue repair and various pathologies. The proposed work seeks to understand the mechanisms that drive collective cell movement. New tools will be developed to activate, monitor, and analyze a critical molecule involved in collective migration, thereby enabling the identification of pathways and cellular behaviors that can be manipulated to control this process in pathological conditions.